Center Core Grant for Vision Research

Overall Component
Abstract
NEI-supported investigators from Duke University request continuing support for a Center Core Grant for
Vision Research. Research areas covered by this group range from basic mechanisms of cellular function to
functional organization of neuronal circuits, with particular interest in identifying innovative potential therapies
to cure common eye disorders.
For the past 35 years, we have used the NEI Core Grant to develop and update our shared resource modules,
thus enhancing the capabilities of individual NEI-supported investigators to conduct vision research. The Core
Grant effectively provides equipment and services that are not readily supported by individual research grants,
as well as stimulating a collegial atmosphere conducive to sharing current techniques and ideas. Both are
critical to success of individual investigators and members of their laboratories. Furthermore, the infrastructure
created with support from this grant aids the recruitment of new investigators and facilitates the participation of
clinical ophthalmologists in vision research, including the development of clinician scientists. Altogether, this
supports and facilitates the translation of the discoveries from basic research into new diagnostic and
therapeutic applications directly related to human eye diseases.
We request support for four resource modules: Morphology/Image Processing, Mass Spectrometry/Molecular
Biology, Animal Models and Flow Cytometry. Support of these shared resources is vital to the creation of
synergy that will give impetus to our vision research group in reaching a level of success that is greater than
the sum of the individual investigator's expected achievements.

Public health relevance
Overall Component Narrative This grant supports facility infrastructure that enhances the capability of individual laboratories at Duke University to address basic molecular mechanisms, pathophysiology, biomarkers and outcomes of multiple blinding diseases, including but not limited to: age-related macular degeneration, glaucoma, retinitis pigmentosa, uveitis and dry eye. This grant also provides a collaborative environment critical for productive interactions among basic and clinician scientists and for raising the next generation of researchers studying biology and pathology of the visual system.